Gene Regulation by RNP Granule Formation in Atherosclerosis

PROJECT SUMMARY
Atherosclerosis, the leading cause of cardiovascular disease related death, is a chronic inflammatory condition
incited by the accumulation of low-density lipoproteins (LDL) and recruitment of macrophages in the arterial
intima. A better understanding of the role ribonucleoprotein (RNP) granules play in regulating the innate immune
system, may reveal important mechanisms underlying this maladaptive inflammatory response in
atherosclerosis. We hypothesize that macrophage transformation into a foam cell state, a process that requires
transcriptional rewiring, is facilitated by stress granules (SGs). SG formation is increased in plaque macrophages
of atherosclerotic mice and can be induced in vitro during cellular cholesterol loading. To test our hypothesis, we
using immunohistochemistry observed that the SG protein, G3BP1, is significantly increased in progressing
plaques compared to regressing. Using centrifugation, we isolated SGs from bone marrow derived macrophages
treated with atherogenic stimuli, and found enrichment of cholesterol efflux transcripts within the SG, suggesting
that SGs play a role in cholesterol homeostasis. Using imaging and RNA-seq of macrophages treated with
siG3bp1 and Dil-oxLDL, we found that G3bp1 knockdown reduced lipid binding, uptake, macrophage phagocytic
capacity, and efflux. Altogether, these data support a role for SGs in dysregulating cholesterol pathways in plaque
macrophages during atherosclerosis progression. In this proposal, I aim to characterize stress granule formation
in macrophages exposed to atherogenic stimuli in vitro and identify the RNA transcripts and RNA-binding
proteins sequestered. By investigating post-transcriptional modifications, I will uncover the mechanism by which
transcripts are marked for sequestration or escape from SGs. Additionally, I will use in vivo mouse models of
atherosclerosis to determine the temporal kinetics, cellular localization, and quantity of SGs per cell over disease
course. I aim to test the therapeutic potential of targeting SGs by perturbing SG formation using (1) G3BP1fl/fl
iLysMcre (genetic) and (2) Ldlr–/– with a small molecule inhibitor of SG formation, ISRIB (therapeutic), in
atherosclerotic mice and characterize plaque burden. Collectively, the proposed investigation into RNP granules
in atherosclerosis, will reveal novel mechanisms of post-transcriptional and innate immune regulation, and
provide foundational studies for new therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Atherosclerotic cardiovascular disease (ASCVD) is a leading cause of death worldwide. Despite significant advances in treatment options, CVD mortality rates have remained stagnant, revealing an urgent need for innovative CVD research and treatment. To date, there have been no studies investigating the specific RNA transcripts influencing macrophage phenotype sequestered in RNP granules in atherosclerosis to target this axis for therapeutic purposes.